The Role of Mitochondria in Dysregulated Insulin Secretion in Obesity

ABSTRACT
Hyperinsulinemia precedes the development of Type 2 Diabetes (T2D) and is thought to play a key role in β-cell
failure by increasing secretory workload. While hyperinsulinemia is thought to act strictly as a compensatory
response to peripheral insulin resistance, recent evidence supports a pathological role by promoting obesity,
hyperlipidemia and hepatic steatosis. Numerous studies demonstrate that dysregulated secretion is intrinsic to
the beta cell since increased levels of secretion at fasting glucose concentrations persist in islets isolated from
obese animals and human. During normoglycemic fasting, an increase in insulin release can occur independently
of glucose, to cause an insidious desensitization to insulin actions. Previous studies in obese mice and new
studies in pre-diabetic humans reveal that islets can acquire a new form of insulin secretion that is driven by fat,
rather than glucose, thereby permitting insulin secretion at fasting glucose concentrations. This form of
malfunction is known as Fatty Acid Induced Insulin Secretion (FASIS): the ability of fatty acids to stimulate insulin
secretion at non-stimulatory glucose. The molecular determinants of FASIS and its contribution to T2D
development are uncharacterized. We hypothesize that mitochondrial fragmentation in beta-cells induced
by exposure to high fat is the major event inducing FASIS. Our preliminary data show that fragmentation
elevates fat oxidation (FAO) in beta-cell mitochondria, by unleashing fatty-acid import into mitochondria,
revealing a new role of mitochondrial architecture in fuel preference. We provide new evidence that high fat
exposure induces fragmentation by destabilizing Mitofusin 2 (Mfn2), via a decrease in Ubiquitin C-Terminal
Hydrolase L1 (UCHL1) activity. This project will provide the unprecedented molecular mechanism by which
FASIS occurs, as well as determining the major effector downstream of decreased UCHL1 activity in T2D. Our
aims will: A) Determine the role of mitochondrial fragmentation in the acquisition of FASIS. We will use
genetic and pharmacological tools to elongate or fragment mitochondria, and determine the effect on FASIS. B)
Determine how mitochondrial shape controls fatty acid utilization in beta cells. We will delineate whether
a genetic and metabolic induction of fragmentation is sufficient to allow for uncontrolled CPT1 activity, while
forced elongation decreases CPT1-dependent FAO. We will further establish whether FASIS depends on
unregulated CPT1 activity and FAO that are induced by mitochondrial fragmentation. And C) Establish the
mechanism by which high fat induces mitochondrial fragmentation in beta cells. We will investigate the
effect of excess fat and glucose on mitofusin-2 turnover, and follow our preliminary data showing that exposure
of beta cells to fatty acids result in decreased levels of UCH-L1, a de-ubiquitinase that controls Mfn2
ubiquitination and turnover, whereby restoring UCH-L1 activity restores Mfn2 levels.

Public health relevance
NARRATIVE Development of diabetes is characterized by dysregulated insulin secretion where patients with pre-diabetes show higher levels of blood insulin that contribute to the development of diabetes and obesity. In this study we will reveal a novel mechanism by which changes to beta cells result in making the beta cell responding with insulin secretion to blood lipids rather than to glucose, leading to uncontrolled secretion. We identify new targets for the development of drugs that will prevent dysregulated secretion.